Longitudinal outcomes of hearing-impaired children: early vs later intervention

Project Summary/ Abstract Permanent childhood hearing loss, which occurs in 1-2/1000 live-births, has negative impacts on children's lives, at high societal cost. Universal newborn hearing screening (UNHS) offers hope for early treatment. However, UNHS is costly, and evidence of its effectiveness in improving long-term outcomes, at a population level, was lacking. By capitalizing on a unique service and research environment in Australia - where children access uniform hearing services from a single provider (Australian Hearing, AH) but had differential access to UNHS during a narrow time window - we addressed the evidence gap by conducting the Longitudinal Outcomes of Children with Hearing Impairment (LOCHI) study. The funding from NIH enabled us to assemble a population-based cohort of 450 children with significant bilateral hearing loss (53% fitted with hearing aids before 6 months of age). We measured their outcomes from diagnosis to 5 years of age. We found that early implantation was positively linked to better outcomes for profound loss, but early hearing aid fitting had limited gains for children with less severe loss. As the cohort ages, the effectiveness of UNHS may alter as benefits in additional domains may be measured. In showing the limited gains made by UNHS and early fitting alone, our findings galvanize new research into how to effectively intervene to capitalize on early treatment for improving outcomes. This application is for Phase 2 of the LOCHI study. The objectives are to investigate the efficacy of early intervention for improving long-term population outcomes, across the entire spectrum of hearing loss: children with mild or unilateral hearing loss (MUHL), which occurs in 1-2/1000 live-births, are also identified via UNHS but for whom audiological treatment is controversial. We propose to measure outcomes of the LOCHI cohort at age 9 years in an expanded range of domains; and to include a randomized controlled trial of intervention for a new cohort of children with MUHL. Our specific aims are: 1) describe the speech, language, literacy, mental health and quality of life of children who received early or later intervention; 2) identify modifiable factors that influence performance outcomes and standard score trajectories; 3) determine predictability of early outcomes for later development to identify the critical age at which children with poor outcomes at age 9 years can be reliably detected; and 4) investigate cognitive abilities and learning strategies of children. All outcomes data and a wide range of predictors will be evaluated in multiple regression analyses. The data and results will be incorporated in a software tool that we will develop to facilitate clinical use. As the research arm of AH, we will minimise loss to follow up by maintaining contact via the service provision network. Achieving the aims will provide the evidence base to 1) guide best-practice intervention following diagnosis across the spectrum of hearing loss; and 2) demonstrate outcomes affected by access to early intervention.

Public health relevance
Project Narrative Project title: Longitudinal Outcomes of hearing-impaired children: early vs later intervention Relevance This study examines the effectiveness of universal newborn hearing screening (UNHS) by taking advantage of a unique research and service environment in Australia to conduct a population-based study comparing outcomes of early- and late-identified children in a prospective manner. This study will generate definitive evidence on the impact of congenital permanent hearing loss on children's development over the first 10 years of life; and determine factors affecting outcomes and rate of growth. It will also provide evidence on the impact of mild or unilateral hearing loss and the efficacy of early intervention. The findings will translate to improved population health by providing evidence on which to base clinical service delivery. The study will also assist future public health research in the field of hearing loss by means of making available a population-based cohort of early- and late-identified individuals with congenital hearing loss who can be followed longitudinally.